Explosive Evolution Under Stress: The Driving Forces of Cancer Dynamics (Main)

DESCRIPTION (provided by applicant): The Center Organization and Infrastructure represents the operational backbone of this PS-OC. It will provide the overall communications network, management structure, administrative support, fiscal oversight, and linkage to all the projects and cores of the center. It will coordinate all project meetings, meetings of the internal and external committees which are part of the center and interface with other PS-OCs of the network. It will generate progress reports - both scientific and fiscal - for submission to NCI and will oversee the budget of each project and activities related to pilot and trans-network projects. The center Administrative team will maintain minutes of all Project meetings and will provide ad hoc support or problem-solving capability for Projects and others critical functions of the center. Collaborations between investigators and between projects will be encouraged and fostered through regularly scheduled meetings of the investigators and staff and by holding periodic scientific retreats. The administrative activities will be facilitated by centralizing bookkeeping functions, coordinating manuscript preparation, and planning travel and research group meetings. The management body of the center will consist of the Principal Investigator, Co-Principal Investigator, center administrative director, director of the education &training and outreach &dissemination activities of the center and the leaders of each of the 4 technical projects. This team will work closely the center administrative committee and the Principal Investigator and Co-Pl will represent the center on the PS-OC network steering committee. Decisions of what pilot projects are funded and what trans-network projects are realized will be made from a joint consensus of members of the center leadership &management and advisory committees.